A Uniquely Scalable Approach to Sequence Tens of Millions of Single Cells Without Compromising Performance

Immunotherapies (including CAR-T cell therapies) are wonder drugs when they work, but the
response rates of today’s immunotherapies are only 15-20% and therapy costs remain
prohibitively high for mass adoption. Recent advances in single cell sequencing make it a critical
tool for the development of next generation cell therapies through high impact applications such
as TCR immune profiling and pooled CRISPR screening. Unlocking the value of these
applications requires interrogation of >10 million cells per experiment. Expiration of Illumina’s core
IP in 2023 re-ignited competition in US & EU markets and re-accelerated the drop in DNA
sequencing costs to make sequencing of ~10 million cells affordable in 1-2 years, but existing
methods for single cell barcoding do not support throughput beyond 1 million cells per experiment.
Proposed alternatives are scalable, but trade-offs in performance and ease-of-use make them
unsuitable for translational research. Sansimeon’s approach uniquely enables scaled single cell
sequencing with throughput to 100M cells, while retaining high ease-of-use and necessary cell
capture efficiency for high-throughput applications in translational research. The platform
overcomes throughput limitations common to other drop-seq approaches by leveraging rapid
deterministic pairing of single cells with single beads in a microchannel prior to emulsification,
without the need for multi-step labeling workflows such as cell-hashing or combinatorial indexing.

Public health relevance
The ability to sequence >10 million single cells per experiment can enable researchers to develop the next generation of immunotherapies (including CAR-T therapies). The forecasted drop in DNA sequencing cost will make sequencing of 10 million single cells commercially viable in roughly 1- 2 years, but existing methods for single cell barcoding do not support throughput beyond 1 million cells per experiment. Proposed alternatives are scalable, but trade-offs in performance and ease- of-use make them unsuitable for translational research. Sansimeon’s platform will enable sequencing of 10 – 100 million single cells without the need for multi-step workflows or reductions in signal:noise and cell capture yield.